CORE--IMAGING

The Imaging Core provides supervised access to, and maintenance of state-of-the-art imaging equipment. It also provides expertise and instruction to the participants of the Component Projects.